CTSA K12 Program at University of Utah: Early Career Faculty Development Program

ABSTRACT
The proposed Utah Clinical and Translational Science Institute (CTSI) K12 career development training
program will build a foundation for junior investigators to achieve fulfilling careers in translational research by
preparing them for external career development or independent research awards. This application requests
support to build on the programmatic successes of our prior KL2 program by increasing the number of scholars
to 5, each for 2 to 3 years, and through innovative programming designed to maximize principles of
translational science. During the prior KL2 period, the program more than doubled in size, increased the K to R
transition from 17% to 50% and increased the number of Under-Represented in Medicine (URM) Scholars by
43%. The proposed leadership team is highly experienced and well-integrated in the CTSI through active
involvement in mentor training and the T32 and R25 programs. The team is also integrated with Module C1,
both as grant writing instructors in the formal degree program and in workshops for faculty seeking their first
R01. The proposed K12 aims to 1) recruit and support a diverse group of scholars, with particular emphasis on
attracting URM scholars and those with diverse career paths, 2) expand the K12 career development
curriculum to include training in translational science and research dissemination, and 3) maximize the
proportion of K12 scholars who achieve independent research support within 5 years of completing the training
award. The proposed K12 program focuses on supporting individualized training plans for scholars conducting
clinical and translational research (T1-T4) using the principles of translational science as well as purely
translational science projects. In addition to the 5 scholars supported by the K12, our career development
program will also include up to 6 additional scholars supported by CTSI partner institutions and supplemental
grants. Key programmatic elements include our highly successful Matrix Mentoring Model, interdisciplinary
mentoring teams, and guaranteed acceptance into a 2-year institutional program focused on training junior
investigators in career development, grant writing, management and leadership. Additional programmatic
elements include didactic training in implementation science with the opportunity to earn a certificate, mini-
immersions in translational research and science across the CTSI (clinical trial services, Biomedical
Informatics, biostatistics, epidemiology, research design, and community collaboration & engagement), twice
monthly K Club focusing on translational science and research ethics, and assorted research forums including
a quarterly virtual translational science roundtable, a collaboration with the University of Texas Health Science
Center at San Antonio’s CTSA. Our training opportunities are designed to ensure that scholars develop the
characteristics of clinical and translational researchers through novel curricular advancements that focus on
translational science and communication skills. The program’s aims are paired with measurable outcomes and
our evaluation team will use a results-based accountability and value engineering framework.

Public health relevance
PROJECT NARRATIVE The proposed Utah Clinical and Translational Science Institute K12 career development training program is intended to build a foundation for junior investigators in the health sciences to achieve fulfilling careers in translational research and science. Scholars will receive 2 to 3 years of support and training opportunities designed to ensure that they develop the characteristics of clinical and translational researchers through novel curricular advancements that focus on translational science and communication skills.